Determining the effects of non-invasive brain stimulation to improve quadriceps muscle function after ACL reconstruction.

Project Summary/Abstract
Quadricep muscle impairments persist for years after anterior cruciate ligament reconstruction (ACLR). They
are linked to poor long-term outcomes including the early onset of post-traumatic knee osteoarthritis (PTOA),
which is thought to result from altered movement patterns (i.e. walking and running) and persistent quadriceps
muscle impairments. Despite use of evidence-based postoperative rehabilitation protocols, the prevalence of
PTOA following ACLR remains at approximately 40% after a mean follow-up of 15 years. Thus, approximately
100,000 individuals who undergo ACLR each year will develop PTOA between the ages of 30 and 40 years,
imposing a substantial burden on the U.S. healthcare system and significantly impacting quality of life. Recent
evidence suggests that lower neural drive, (i.e., lower corticospinal excitably (CSE)), is associated with
pronounced quadriceps muscle performance deficits, which are more severe in females recovering from ACLR
than in males. Current postoperative rehabilitation protocols do not target lower neural drive, which can be
achieved through non-invasive brain stimulation. Thus, the long-term goal of this research is to improve the
effectiveness of ACLR rehabilitation. The objective of this R15 project is to determine if neural drive is the
critical missing link in ACLR rehabilitation. To meet this objective, we will administer anodal transcranial direct
current stimulation (tDCS), a type of non-invasive brain stimulation known to increase CSE. We will then
assess whether it improves three measures of quadriceps muscle performance (in Aim 1) and two measures of
CSE (in Aim 2). In Aim 3, we will determine the relationship between observed changes in quadriceps muscle
performance and CSE in female participants recovering from ACLR. These aims will be achieved using a
randomized, triple-blinded clinical trial with 42 female individuals after ACLR between the ages of 18 and 35
years. All participants will receive six sessions of active or sham anodal tDCS while they perform isolated
quadriceps exercises on an isokinetic dynamometer. The two measures of CSE (i.e. active motor threshold
and the slope of transcranial magnetic stimulation (TMS) induced recruitment curves) will be determined using
surface electromyography on the vastus medialis and TMS. Three measures of quadriceps performance (i.e.
peak torque normalized to body weight, rate of torque development (RTD) from 0-100ms and 100-200ms, and
torque steadiness) will be determined following standard isometric muscle testing on an isokinetic
dynamometer with the hips flexed to 90° and the knees flexed to 60°. Statistical analyses will include repeated
measures analyses of variance (Aims 1 & 2) and Pearson correlations (Aim 3). Findings from this study will
determine if a form of non-invasive brain stimulation improves quadriceps muscle performance, setting the
stage for new post-ACLR rehabilitation protocols. Additionally, follow-up research will assess whether the
restoration of neural drive corrects altered movement patterns, and in the long-term, ultimately reduces risk of
PTOA.

Public health relevance
Project Narrative Approximately 40% of individuals recovering from anterior cruciate ligament reconstruction (ACLR) will develop post-traumatic knee osteoarthritis (PTOA) within 15 years of surgery, posing a substantial burden on the United States healthcare system. Quadriceps muscle deficits are persistent after ACLR, contributing to chronic movement alterations and the development of PTOA. The proposed study will fill a gap in determining the cortical mechanisms underlying quadriceps impairment by examining the effects of non-invasive brain stimulation on cortical excitability and quadriceps muscle function.